Midcareer Mentoring Award for Patient-Oriented Research in Chlamydia trachomatis Infection

This application is for a renewal of my K24 Midcareer Investigator Award in Patient-Oriented Research
(POR) on Chlamydia trachomatis (CT) Infections. I, Dr. William Geisler, am a federally-funded physician
scientist at the University of Alabama at Birmingham (UAB) with expertise in CT infections and significant
mentoring experience. During the initial K24 period, I obtained new funding (R01 renewal, a new R01, a new
R21, etc.), expanded my POR program in new directions, had 35 publications, became UAB Assistant Dean
for Physician Scientist Development, and mentored 16 early stage investigators who had many successes
(awards included a K08, KL2, TL1, an F30, an F31-D, etc.). The protected time afforded by this K24 renewal
would enable me to: 1) broaden my mentoring knowledge and develop new research skills, 2) continue
providing POR mentoring to early stage investigators, and 3) expand my research program in new directions.
Despite current CT prevention and control efforts, CT infection rates continue to rise and CT remains the most
prevalent bacterial STI worldwide, one with significant disparities in women and African Americans and
associated with reproductive morbidity. A CT vaccine is urgently needed. However, a better understanding of
immunogenetic determinants that impact CT infection risk and which CT antigens are most immunogenic and
induce protective immunity to CT is needed to advance vaccine development; My Current POR is focused on
this need (2R01AI093692 and 1R01AI148359). CT vaccine availability does not ensure it will be utilized.
Lessons learned from HPV vaccine implementation have taught us that psychosocial and behavioral factors
influence STI vaccine acceptability and studies on factors impacting CT vaccine acceptability are needed.
In this K24 renewal, I plan to broaden my mentoring knowledge through didactic and interactive
experiences, develop new research skills in entrepreneurship and research commercialization through didactic
and experiential training under mentorship, and continue mentoring early stage investigators in POR. Mentees
will be provided with educational and research experiences tailored to their career stage and interests.
Mentoring will be on my Current CT immunogenetics POR (noted above and discussed in detail in this
application) and on two new POR studies suported by this K24 renewal award that will expand my CT POR
program. New Study 1 aims to determine if HLA-DQB1*06 and CT-specific CD4+ IFN-g can be useful
biomarkers for predicting incident CT infection; I previously found that DQB1*06 was a risk marker and CD4+
IFN-g a protective marker for CT reinfection. Findings can be used to guide CT testing frequency in women
based on incident CT infection risk determined by the biomarkers. New Study 2 seeks to identify enabling and
limiting factors that affect acceptability of a CT vaccine through surveys and qualitative interviews to aid in
designing strategies to increase CT vaccine uptake. The long-term goal of my POR is to improve prevention
and control of CT infection. Thus, knowledge from Current POR and new studies addresses this goal.

Public health relevance
The primary goals of my K24 midcareer investigator award renewal application are to enable me, William Geisler, M.D., M.P.H., to: 1) broaden my mentoring knowledge and develop new research skills, 2) continue providing patient-oriented research mentoring to early career stage clinical investigators, and 3) expand my research program in new directions. The public health importance of the research is that it addresses the need to improve chlamydia prevention and control efforts by advancing chlamydia vaccine development, providing important knowledge on factors that will influence acceptability of a chlamydia vaccine, and evaluating biomarkers that could be used to guide chlamydia screening strategies. Mentoring provided by me should advance the research skills and career development of many early career stage clinical investigators.